Uncovering the fundamental principles of transcriptional regulation

Project summary/Abstract
The regulatory code, inscribed in DNA, speciﬁes how the expression of a gene will be tuned by transcription
factors (TFs) in response to an environmental or intracellular stimulus. This code sets how each individual gene
responds to stimuli by controlling when and where TFs bind. In my lab, our work is dedicated to developing a
predictive understanding of gene expression. This is accomplished through a close interplay between quanti-
tative theoretical predictions based on detailed biophysical models, and an experimental approach guided by
falsiﬁable predictions for the quantitative consequence of systematic perturbation applied to a synthetic target
gene. The work in my lab, which uses E. coli as a model organism, focuses on the systematic dissection of two
distinct roles of regulatory binding sites in gene expression:
The regulatory role of individual, local “cis-regulatory” binding sites.
The regulatory role of non-local, competing binding sites scattered throughout the genome.
To characterize local, cis-regulatory interactions we use a synthetic biology approach to systematically measure
the regulatory function of every TF as a function of where on the gene it binds and to what sequence it binds.
Through this process we will uncover the isolated function of each TF in the absence of the gene-speciﬁc factors
(such as feedback and TF-TF interactions) that occlude this basic information in genomic data. To study the role
of competing binding sites, we use this same synthetic biology approach to control the number and strength of
TF binding sites to measure how competition for TFs controls spatial and temporal patterns in gene expression.
Taken together, these directions of investigation are aimed at providing a complete picture of regulation at
the level of a single gene. These methods are not orthogonal, it is difﬁcult to study one without appreciating
the other; to quantify how competition alters expression we must understand the “isolated” regulation of the
local regulatory elements acting alone, and to study local regulatory elements we must understand the impact
of the unavoidable, naturally occurring competing binding sites around the genome. Our approach is designed
to isolate and quantify these regulatory effects to provide the foundation required to predict expression from the
complex regulatory schemes observed in natural genes.
In the next 5 years, we will demonstrate that by characterizing individual TF function based on binding location
and sequence, we can disentangle the role of gene-speciﬁc features from basic TF function in order to under-
stand how these components act together in the complex regulatory regions seen in naturally occurring genes.
Furthermore, we will develop a theoretical model that accounts for the role of TF competition in orchestrating
expression patterns in space and time that are crucial for cellular decision making and ﬁtness.

Public health relevance
Project Narrative The regulation of gene expression is a fundamental process responsible for steering cells towards their fate and responding to external stimuli and misregulation of particular genes results in a broad range of diseases. The regulatory code, inscribed on the DNA, plays a major role in recruiting the proteins responsible for gene regulation, but we do not know how to read and interpret this code. My lab aims to decipher the regulatory code through fundamental synthetic biology experiments that reveal the basic principles of gene regulation.